Epidemiology and Clinical Research Informatics Shared Resource

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
EPIDEMIOLOGY AND CLINICAL RESEARCH INFORMATICS SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Epidemiology and Clinical Research Informatics Shared Resource (ECRISR) serves a crucial role in
support of both epidemiological and clinical trial research management by providing overall research
management expertise and informatics-based management solutions to MECC investigators. ECRISR has
extensive experience supporting all aspects of epidemiological research with a focus on the development of
Study Management Systems (SMS), which facilitate the diverse management, data, and operational aspects of
implementing complex protocols. SMS incorporates automated workflow processes across shared facilities,
implement Quality Assurance (QA) and best practices in order to ensure data integrity, automate data integration
from various sources, and establish real-time data monitoring to provide efficient research operations, improved
data access, and progress/regulatory reporting. SMS integrates with internal and external Electronic Health
Record and laboratory systems, and support management of multi-center clinical research projects.
ECRISR is responsible for the development, implementation, and oversight of a comprehensive clinical trial and
research management process to standardize and streamline MECC clinical trial and research process
management. This shared resource has extensively customized the functionality of the Velos eResearch Clinical
Trial and Research Management System (CTRMS) to provide QA oversight and facilitate compliance/monitoring
of all clinical trial activity. ECRISR has established workflows, policies, and procedures that collaboratively
engage, guide, and/or provide oversight to other shared resources. The research management process spans
the lifecycle of protocol management from IRB submission to completion and the ECRISR continually expands
the purview of the overall process with the design of custom interfaces between the CTRMS, EPIC, and multiple
IRB institutional systems to provide fully integrated regulatory and operational management of clinical trials.
ECRISR provides competency and capacity to develop scalable and robust informatics infrastructure that
leverage big-data analytic resources to enable a wide spectrum of research. This shared resource maintains a
sophisticated applications framework with data governance and security protocols in compliance with national
standards and provides interoperability with other systems to create patient-centered, integrative informatics
platforms for comparative effectiveness and preventive care research. We provide novel solutions in the realm
of data extraction and QA. ECRISR strives to foster interdisciplinary collaboration, serves as a data coordinating
center, provides data management services, assists in the development of pilot and grant proposals, and works
closely with biostatisticians in the production of complex databases and publications.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward EPIDEMIOLOGY AND CLINICAL RESEARCH INFORMATICS SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page